Task 4: The Interventional Agent Development Services Program

This contract provides for preclinical microbiological, safety, toxicology and biokenetics services under the NIAID Preclinical Services for the Development of Interventional Agents Program for infectious diseases.